Effect of GABAergic inhibition of dendritic spines on synaptic pruning in the medial prefrontal cortex during adolescence

Dendritic spines undergo synaptic pruning in the medial prefrontal cortex (mPFC) during adolescence,
a process which is excessive in schizophrenia, believed to underlie cognitive impairment. Despite its
importance, the mechanism underlying synaptic pruning in the mPFC is not known. Our preliminary
findings suggest that extrasynaptic α4βδ GABAA receptors (GABARs), which transiently emerge on the
spine at puberty onset (~PND 35) for 10d, trigger adolescent synaptic pruning in the mPFC. These
receptors generate a shunting inhibition which impairs NMDA receptor activation. Our previous findings
in CA1 hippocampus established that the inhibition generated by these receptors reduces expression of
the Rho-GEF spine protein Kalirin-7, necessary for spine maintenance, via this reduced NMDA receptor
activity. We will test the hypothesis that similar effects on spine proteins play a role in adolescent
pruning in mPFC. The proposed aims will use multiple techniques, including in vivo two-photon
imaging, electrophysiological, pharmacological, and immunocytochemical assays. To this end, we will
chronically manipulate α4βδ function during adolescence (~PND 35-44) and quantify spine density at 8
and 12 wks of age. Preliminary data shows that spine density is decreased in both layer 3 and 5 post-
pubertally in +/+ but not α4-/- mice, implicating α4βδ GABARs. Because synaptic GABAergic input
targets the spine in the cortex, the role of α1β2γ2 GABARs will also be examined. These experiments
will use acute pharmacological (agonists, modulators) and genetic manipulation (global/conditional/local
knock-down) of α4βδ and α1β2γ2 to explore the role of these receptors in regulating spine density and
morphology assessed using Golgi and electrophysiological techniques. To explore the effect of this
pruning on circuit and behavioral plasticity, in vivo two-photon techniques in combination with multi-
neuron recording will be used to image the Ca++ signals and record activity generated by neuronal
ensembles in response to visual stimuli in the awake mouse across adolescence and after GABAR
modulation/knock-down. We will thus assess the effect of pubertal α4βδ GABARs and GABAR-
generated pruning on circuit function, including the power and synchronization of theta and gamma
oscillations as well as on circuit activity/synchronization of ensembles and mPFC-dependent learning
tasks. The findings from the proposed studies will directly address the functional role of GABAergic
inhibition on dendritic spines at puberty, and will also provide mechanisms for the process of synaptic
pruning, as well as explore functional outcomes of alterations in this process. These results are relevant
for schizophrenia where excessive synaptic pruning and impaired working memory are reported in
association reduced power/sychronization of visually-evoked gamma oscillations, and where single
nucleotide polymorphisms of the δ gene are reported, suggesting a genetic link.

Public health relevance
Schizophrenia is a disabling mental illness associated with excessive synaptic pruning in the prefrontal cortex which likely underlies the cognitive deficits associated with this disorder. The mechanism underlying synaptic pruning of this region during adolescence is not yet known and will be addressed in this proposal by examining the role of a novel inhibitory receptor, the α4βδ GABAA receptor, which emerges at puberty in the prefrontal cortex and has been found to be defective in some cases of schizophrenia. The proposed experiments will use state of the art imaging, recording and behavioral techniques as well as genetic manipulations to examine normal and abnormal pruning, similar to that found in schizophrenia and autism, which may suggest novel therapeutic strategies.